Administrative Core

SUMMARY
The central purpose of a P01 Program is to support integrated research involving independent investigators who
share research capabilities and resources toward a common goal. Essential to this effort is scientific rigor and
reproducibility in all aspects of the research effort. To accomplish this, the Administrative Core will oversee the
performance of all aspects of the proposal and provide statistical support to ensure the appropriate design and
analysis of experiments. The Core proposes the following Specific Aims:
Specific Aim 1: Manage all program-related administrative activities.
Core A will be responsible for management of the budget, preparation of non-competing renewals,
communication with the NIH, fiscal oversight, disbursement of funds, and general scientific oversight of the
Projects and Cores.
Specific Aim 2: Provide statistical support for the experimental efforts conducted through the Projects.
Core A will be responsible for ensuring statistically-rigorous and transparent research in all areas supported by
the P01. This will include statistically-appropriate experimental design, including power and sample size
calculations, and modeling and data analysis that considers relevant biological variables. Additionally, Core A
will focus on adherence to reproducibility standards in all grant-related activities.
Specific Aim 3: Maintain compliance with appropriate regulations.
Core A will ensure that all Projects and Cores comply with regulations governing experimentation with vertebrate
animals, biosafety, deidentified human specimens and other relevant federal, state, local, and institutional
regulations.
Specific Aim 4: Coordinate, schedule, and lead all scientific meetings.
Core A will coordinate scientific meetings to maximize interactions between Projects, provide critical input into
ongoing research efforts, and ensure effective utilization of Cores. Core A will organize and lead monthly
meetings of the P01 leadership and members of their respective laboratories, and will coordinate annual
meetings with the Scientific Advisory Board.